Creation of a knowledgebase of high quality assertions of the clinical actionability of somatic variants in cancer

Project Summary
Interpretation of the clinical significance of somatic variants in cancer remains a major challenge in cancer
diagnosis, prognosis and treatment prediction. The Clinical Genome Resource (ClinGen) has established
extensive infrastructure including tools, web resources, procedures, and expert panel templates to help
communities of experts establish the clinical relevance of genes and variants. However, ClinGen’s effort is
almost exclusively focused on the interpretation of germline variants and their role in heritable phenotypes,
leaving a significant gap in clinical interpretation of somatic variants in cancer. Concurrently the Global Alliance
for Genomics in Health (GA4GH) has begun to develop standards for genomic data interoperability. The
Clinical Interpretation of Variants in Cancer (CIViC) resource provides a sophisticated variant knowledge
curation interface. In this application, we propose to create a knowledgebase of high quality assertions of the
clinical significance of somatic variants in cancer that utilizes the CIViC platform, adapts the procedures of
ClinGen to somatic variant interpretation and implements the interoperability standards of the GA4GH. This
effort is needed to broadly enable research and clinical translation involving the use of somatic cancer variant
knowledge as it relates to oncogenicity, diagnosis, prognosis and therapeutic response. By adapting the
ClinGen germline model, we will establish processes to engage the expert community and facilitate the
creation of Somatic Cancer Variant Curation Expert Panels (SC-VCEPs). Formation of these SC-VCEPs will
support creation of a ClinGen Somatic Knowledgebase of clinical cancer variant assertions curated and
approved by experts. SC-VCEPs will be the primary drivers of curation and domain specific guideline creation.
We will adopt and guide ongoing development of several emerging standards that enable the Findable,
Accessible, Interoperable, and Reusable (FAIR) principles for genomic knowledge sharing. Specifically, we will
adopt the GA4GH Variation Representation Specification (VRS) and associated genomic knowledge
framework of the GA4GH Genomic Knowledge Standards (GKS) Work Stream. We will also use our
expert-driven curation activities to inform and develop curation and minimal information standards. Finally, we
will use natural language processing (NLP) to accelerate a set of defined human knowledge curation tasks that
currently limit the rate of human curation. Specifically, NLP will be used to (1) streamline curator activities
through integration of text-mined data directly into CIViC; (2) prioritize papers based on their likely evidence
level such as clinical trials or case reports; (3) identify and match a larger variety of cancer variant types
through a variant hierarchy system; and (4) automate simple but time-consuming tasks such as enforcing
consistent synonym usage. Our ultimate goal is to support a large community of domain-specific expert panels
working together to create a public knowledgebase of cancer variants and their clinical relevance.

Public health relevance
Project Narrative Cancer is driven by DNA mutations which can increasingly be used to determine the type, likely outcome and best treatment options for individual patients. Establishing the clinical relevance of each mutation requires experts to review and summarize a growing body of evidence. By coordinating the efforts of these disease experts we will build a database of mutations and information that helps doctors guide treatment of cancer patients.